Sending and receiving Hedgehog and Wnt signals

Application for an Administrative Supplement to:
5R01 GM122920-6 “Sending and receiving Hedgehog and Wnt signals”
Abstract
Embryogenesis and adult physiology are orchestrated by a handful of cell-cell signaling pathways[1]. The two
pathways that are the focus of the present proposal, Hedgehog (Hh) and Wnt, play critical roles in
development[2] and adult stem cell maintenance[3]. Insufficient Hh or Wnt signaling is the cause of numerous
birth defects[4], while excessive activation is involved in many cancers[3a, 5]. A common feature of Hh and Wnt
signaling is that they are both triggered by lipid-modified secreted proteins[6]: Hh ligands are modified with
cholesterol[7] and palmitate[8], while Wnts are modified with palmitate/palmitoleate[9]. While lipidation is essential
for signaling function, it makes Hh and Wnt ligands strongly membrane-attached[10], raising the question of how
they spread far from producing cells. We first investigated this question for the Hh ligand, Sonic hedgehog
(Shh)[11]. We discovered that Shh is released as a soluble and potent complex with a secreted carrier protein,
Scube2[12], and that Scube2-Shh formation is catalyzed by the transporter Dispatched1[13] (Disp1), powered by
the plasma membrane Na+ gradient[14]. Scube2-Shh then delivers Shh to its receptor, the tumor suppressor
membrane protein Patched1 (Ptch1)[15], triggering Hh pathway activation[16]. We discovered that the Shh co-
receptors, comprising the homologous membrane proteins Cdon and Boc and the unrelated GPI-anchored
Gas1[17], are essential for moving Shh from Scube2 to Ptch1[18]. Our results defined a pathway whereby
Cdon/Boc recruit Scube2-Shh to the cell surface, after which Gas1 promotes Shh transfer to Ptch1. Finally, we
recently discovered two families of secreted proteins that function as novel release factors and carriers for Wnt
ligands, paralleling the mechanism of Shh release. Our findings open several critical questions about Hh and
Wnt signaling. We propose combining biochemistry, structural, chemical and cell biology to accomplish the
following aims: 1) To determine precisely how Shh is released form the membrane of producing cells; 2) To
elucidate how Gas1 catalyzes Shh-Ptch1 complex formation, to trigger Hh signaling; 3) To determine how Wnt
ligands are secreted and then delivered to responding cells.
These studies are important to undertake for the following reasons: A) They will elucidate the pathways of Shh
secretion and Shh-Ptch1 complex assembly, two crucial but poorly understood steps in Hh signaling; B) They
will define novel mechanisms for the release of Wnt ligands from cells and for how they activate signaling in
responding cells; C) They will define novel targets for blocking Hh and Wnt signaling in cancer, such as their
specific release and delivery pathways; and D) Our novel chemical probes for studying lipids will be broadly
applicable to the cell biology of cholesterol and fatty acids.

Public health relevance
Project narrative Hedgehog and Wnt ligands are secreted proteins that activate two cell-cell signaling pathways that play fundamental roles in embryonic development, adult stem cell maintenance, and are critical for the pathogenesis of numerous human cancers and genetic diseases. We are requesting funds to purchase a multimodal plate reader, which is essential for the majority of our experiments aimed at elucidating key molecular mechanisms that govern how Hedgehog and Wnt ligands are secreted and delivered to their target cells. The studies will have broad impact on human health, by advancing our understanding of how certain types of cancer and birth defects develop, and by defining novel targets and strategies for cancer therapy.